Novel Wnt effectors in renal cystic disease

DESCRIPTION (provided by applicant): Despite the remarkable advances in identifying mutations underlying human genetic disease, the predictive power of the genotype remains poor, in part because the ultimate clinical outcome in each patient is the net result of epistatic interactions between disease causing mutations and second site modifying alleles, as well as stochastic and environmental effects. Bardet-Biedl syndrome (BBS) represents a useful model to study epistasis;several studies have shown that modifying alleles in each of the twelve causative genes, as well as in other transcripts, modulate the penetrance and expressivity of the disorder. BBS also represents a model ciliopathy, an emerging group of clinically distinct but phenotypically overlapping disorders that include polycystic kidney disease (PKD), Nephronophthisis (NPHP), Joubert syndrome (JS) and Meckel-Gruber syndrome (MKS). Recent data have shown that the cilium, and its anchoring structure, the basal body, are required for the transmission morphogenetic cues and that failure of this process can be causally associated with some of the observed clinical phenotypes, such as renal cystic disease. Loss of function of several BBS proteins has been shown to disrupt non-canonical Wnt signaling, which in turn has been associated with some of the cystic phenotypes found in patients and vertebrate animal models. Focusing on the contribution of Wnt signaling to the renal phenotype, we reason that there will be proteins that have the ability to modulate the biochemical effect of loss of function mutations at one BBS locus by either exacerbating, ameliorating, or rescuing defective Wnt transmission. By definition, the transcripts that encode these molecules represent major candidates for contributing penetrance and expressivity modifying alleles in humans, the identification of which will: a) improve exponentially our understanding of genetic load in humans;b) facilitate the clinical management of the disorder;and c) be potentially relevant to the development of renal cystic disease in other ciliopathies. To explore these possibilities further, we propose to 1) investigate ~500 members of the newly defined ciliary proteome in modulating the Wnt signaling response in BBS mutant renal cells by utilizing a combination shRNAs, expression vectors, and luminescent reporters, and 2) explore the physiological relevance of these potential modifier proteins in modulating the renal phenotype of BBS patients by screening candidate genes for a haplotype signature that associates with disease phenotype and sequencing our BBS cohort for modifier alleles.